Overhead for CDC IDDA for Infrastructure Support for Prevention Research Centers Cancer Prevention & Control Network

Overhead for CDC IDDA for Infrastructure Support for Prevention Research Centers Cancer Prevention & Control Network